Administrative Core

The Transdisciplinary Research Consortium for Gulf Resilience on Women's Health (GROWH) is a regional community collaborative network composed of both community and academic partners with a track record of working with vulnerable disaster-prone communities suffering historic health disparities in reproductive health, environmental justice, cancer, asthma, cardiovascular diseases and diabetes for more than 25 years. The overall strategic leadership of the collaborative is driven by the Consortium's overall transdisciplinary, CBPR-driven holistic scientific design, interdependently linking research, evaluation and translation and community outreach and dissemination. The administrative core will be housed at Tulane University as the lead partner institution and will be directed by Dr. Lichtveld. In addition to scientific leadership and strategic oversight, the administrative core will fulfill the following key roles: nurturing the GROWH Consortium partnership network consisting of the triad of communities, frontline public health providers, and academic institutions engaged in CBPR-driven environmental health disparities research through fiscal, logistic, administrative and strategic leadership support; administrative and logistical support for all center components?outreach, research, and training; data security, management and sharing leadership and support including adherence to all human subject requirements; logistic and administrative support for trans core and research activities and interaction with NIEHS serving as the nurturing and coordinating hub for sustaining activities in all three consortium components.

Public health relevance
Women of reproductive age living in Louisiana parishes affected by the Gulf of Mexico oil spill and previously Hurricanes Katrina, Rita and Gustav have increased stressors, are at continuous risk of natural and manmade disasters and have elevated concerns regarding adverse environmental and reproductive health outcomes. The goal of this project is to establish and maintain a Consortium to advance innovative, community-centered, transdisciplinary research focusing on the social detriments of health.